Drug Development Core

PROJECT SUMMARY / ABSTRACT
The Drug Development Core (DDC) directly supports the UWCCC mission to develop innovative therapies by
providing cost-effective, cutting-edge, high-throughput screening (HTS) services; medicinal chemistry and lead
optimization services; and pharmacokinetic (PK) and pharmacodynamic (PD) services to support clinical trials.
These services are supported by extensive expertise, state-of-the-art equipment, and cutting-edge
computational tools for assay design, synthetic chemistry, computational chemistry, analytical chemistry, and
pharmacology. Through a mission-centered set of specific aims, the DDC will achieve a high level of support for
UWCCC members. Specific Aim 1: Advance UWCCC member drug development research by providing
expertise and resources for compound discovery, medicinal chemistry, computational chemistry, and
pharmacology of chemoprevention and anticancer agents. The primary goal of Specific Aim 1 is to provide
the expertise, equipment, and computational tools required to fully enable UWCCC users. Specifically, the DDC
staff will advise on experimental design, data acquisition, and data analysis to ensure rigor and reproducibility of
high impact drug development research in a cost-effective manner. Impact: 13 HTS campaigns, 10 patents, and
10 drug leads. Specific Aim 2: Support clinical trials conducted at UWCCC by providing the expertise and
infrastructure needed to evaluate the pharmacokinetic and pharmacodynamic properties of study drugs.
To achieve this aim, the DDC will provide patient sample storage with a robust and secure database system to
document all samples. Additionally, the DDC will provide analytical expertise to properly sample, analyze, and
quantify drugs and drug metabolites from patient tissues. These services are critical to UWCCC participation in
NCI sponsored UM1 programs, NCI’s National Clinical Trials Network (NCTN), and industry sponsored clinical
trials. In the current funding period, the DDC provided support for 394 UWCCC studies including 209 NCI
sponsored studies. Given the proposed expansion of clinical trials by the Developmental Therapeutics program,
we predict this number to increase in the next funding period. Specific Aim 3: Train UWCCC members, their
staff, and students in drug development processes and the productive use of state-of-the-art equipment
to meet their research goals. The highly experienced DDC staff will ensure that equipment is well maintained,
highly reliable, and available for UWCCC members, their staff, and students on a 24/7 basis. Additionally, the
DDC staff will routinely present studies and new technologies to PI’s, postdocs, and trainees. The DDC has
trained over 168 users associated with the UWCCC during the current funding period. Through these Specific
Aims, DDC will not only support the mission of the UWCCC but also provide direct support to UWCCC members
to maximize their impact and further advance cutting-edge cancer research. DDC supported 109 unique UWCCC
program members across all 6 UWCCC scientific programs and 113 member publications during 2017-2021.

Public health relevance
PROJECT NARRATIVE Per PAR-21-321 instructions, this component is not required.